RHESUS FSH GRANULOSA CELLS HELP NON FSH IN VITRO MATURE OOCYTE DVLPMNT

Objectives Determine if culture of oocytes from nonstimulated macaque monkeys during in vitro maturation (IVM) with freshly recovered granulosa cells obtained from FSH-primed vs. nonstimulated monkeys improves meiotic and developmental capacity of oocytes and confers on them competence to develop into blastocysts in vitro. ABSTRACT:Antral follicles r1mm in diameter were dissected from excised ovaries of 11 nonstimulated rhesus monkeys. Cumulus-enclosed germinal vesicle stage oocytes (n = 282) were randomly cultured in each of three IVM treatments 1) control (no granulosa cells), 2) nonstimulated granulosa granulosa cells (5 x 106 live cells/ml) from nonstimulated monkeys, or 3) FSH-primed granulosa granulosa cells (5 x 106 live cells/ml) from monkeys primed with purified FSH for 8.5 days. All treatments contained gonadotropins (5 g/ml FSH; 10 g/ml LH). Oocytes were cultured for 36-41 h in modified CMRL-1066 medium containing 20% bovine calf serum, then inseminated and cultured in the same medium (minus gonadotropins) until developmental arrest or zona escape. Neither nuclear maturation, fertilization or cleavage to the 8-cell stage differed among treatments. Development to the 9-15-cell stage was improved (Ps0.01) by culture with either nonstimulated granulosa or FSH-primed granulosa cells compared to control. Culture of oocytes with FSH-primed granulosa, but not nonstimulated granulosa cells, enhanced (Ps0.05) development to the morula stage compared to control (23.1, 10.7 and 5.3%, respectively). Oocytes cultured with FSH-primed granulosa cells were more (Ps0.05) competent to develop into blastocysts (6.5%) than control (0.5%) or those cultured with nonstimulated granulosa cells (0.6%). Development into expanded and hatched blastocysts was also improved (Ps0.05) by culture of oocytes with FSH-primed granulosa cells vs. nonstimulated granulosa cells or control. In conclusion, culture of immature oocytes from nonstimulated monkeys with fresh granulosa cells recovered from FSH-primed monkeys enhanced their competence to develop into blastocysts and hatch in vitro, and resulted in the first blastocysts produced in vitro from IVM/in vitro fertilized (IVF) oocytes of nonstimulated primates. Keywords oocyte maturation, embryo, blastocyst, follicle-stimulating hormone priming.